Elucidating the Role of MALAT1 Somatic Driver Mutations in Colorectal Cancer

Tumorigenesis and cancer progression are caused by the accumulation of mutations in driver genes. Distinct
combinations of driver gene mutations cooperate during tumor evolution, revealed by increased frequency of
mutation co-occurrence from evolutionary selection. Recently, long noncoding RNAs (lncRNAs) have been
shown to be cancer driver genes. Here we identified MALAT1 as a novel colorectal cancer (CRC) driver.
MALAT1 CRC mutations are enriched in competing endogenous (ceRNA)-microRNA binding sites, and CRCs
carrying MALAT1 mutations are specifically enriched for BRAF mutations. This is the first systematically
identified example of cooperation between coding and lncRNA cancer driver genes. Here, we will test the
hypothesis that MALAT1 competing endogenous RNA mutations drive colon tumorigenesis, and also test
hypotheses that MALAT1 mutations promote CRC growth and BRAF inhibitor resistance. Our work will provide
unprecedented detail into the precise mechanistic roles of MALAT1 and MALAT1/BRAF mutations, and has
potential impact to drive clinical precision medicine sequencing panel studies of MALAT1/BRAF mutations in
EGFR inhibitor therapy resistance, serrated CRC prognosis, and BRAF/EGFR inhibitor combination therapy
clinical trials.

Public health relevance
Most mutations in cancers do not have significant effects. The relatively few mutations that promote tumorigenesis and progression are referred to as cancer drivers. Hundreds of laboratories, The Cancer Genome Atlas (TCGA), International Cancer Genome Consortium (ICGC), and Pan-Cancer Analysis Working Group (PCAWG) have comprehensively characterized somatic mutation profiles to identify driver genes for many cancers. However, to date these studies have largely focused on coding mutations. Long non-coding RNAs (lncRNAs) are expressed by ~80% of the genome, but their functions are much less well understood than protein coding genes. This study focuses on the roles of a lncRNA cancer driver MALAT1 and interaction with the BRAF oncogene in colorectal cancer. These experiments will elucidate the roles of MALAT1 colorectal cancer mutations and have the potential to identify downstream druggable pathways for precision medicine chemoprevention and treatment of MALAT1 mutant tumors that are likely broadly applicable to other cancers.